Defining the landscape and mechanisms of redox regulation of metabolism during aging

PROJECT SUMMARY: Mammalian tissues engage in specialized physiology that is regulated through reversible
modification of protein cysteine residues by reactive oxygen species (ROS). Despite the longstanding links
between ROS dysregulation and aging, technological limitations have resulted in a persistent absence of
information on the exact protein cysteines are modified by ROS that explain the molecular basis for this
dysfunction in vivo. Using the cysteine-phospho tag (CPT) proteomics technology that I developed, I have
determined that a fundamental remodeling of protein cysteine oxidation networks occurs with caloric restriction
(CR) in aging. Building on this, I will determine the functional role of redox regulation of newfound protein
networks that are linked to the lifespan and healthspan benefits of CR in aging. I have also extended Oximouse
to diversity outbred (DO) mouse populations to recapitulate the genetic diversity of human population, in search
for redox signaling targets that have high translational potential. Preliminary data from this effort has identified
conserved redox signaling targets on proteins that may have critical implications in age-dependent decline of
thermogenesis leading to age-related obesity. I will study metabolic redox signaling nodes underlying longevity-
modifying interventions and delineate the mechanisms through which these targets are redox-regulated with age
that lead to a decline in thermogenic activity. The proteomics data will provide a rich resource for the community
to explore ROS and aging. The mechanistic studies will validate redox signaling nodes that can potentially be
manipulated to extend lifespan and healthspan, in line with the mission of the National Institute of Aging.
Objectives: (1) Defining mitochondrial cysteine oxidation mechanisms underlying the health benefits of CR.
(2) Determining adipose metabolic redox signaling nodes underlying longevity-modifying interventions.
(3) Investigating the mechanisms of redox control in age-related obesity.
The first two objectives will be completed during the K99 phase, and the last objective will be carried out during
the R00 phase. This work builds on a redox proteomics technology that I developed, which quantifies absolute
cysteine redox modification stoichiometry at orders of magnitude deeper proteome coverage than previous
methods. From this big data, I will mechanistically validate individual redox signaling nodes that have important
roles in metabolism and longevity. I will be mentored by Drs. Chouchani and Gygi, who are experts in the fields
of ROS biology, metabolism, animal physiology, and mass spectrometry (MS)-based proteomics. I will
additionally learn from my collaborators/consultants, Drs. Mair, Gladyshev, Banks, Gupta, and Spiegelman, who
have extensive expertise in aging, animal physiology, and metabolism. The rich scientific environment at DFCI
and HMS adds fuel to my enthusiasm to establish myself as an independent investigator. My unique skillset will
allow me to develop novel technologies to study the biology of aging in a “big-data” driven manner, then select
targets for mechanistic validation to provide insights for future translational therapeutic development.

Public health relevance
PROJECT NARRATIVE Despite the longstanding links between oxidative stress and aging, the reason why these links exist is not clear. I have developed a new technology to explore this question to deepen our understanding of how oxidative stress affects the biology of aging, with a particular focus on age-related obesity. The proposed study will pave the way for the development of new therapeutics for lifespan and healthspan extension.